Group testing for infectious disease detection: multiplex assays and back-end screening

Project Summary/Abstract Testing individuals for infectious diseases is important for disease surveillance and for ensuring the safety of blood donations. When faced with questions on how to test as many individuals as possible and still operate within budget limits, public health ofﬁcials are increasingly turning toward the use of group testing (pooled testing). In these applications, individual specimens (such as blood or urine) are combined to form a single pooled specimen for testing. Individuals within negative testing pools are declared negative. Individuals within positive testing pools are retested in some predetermined algorithmic manner to determine which individuals are positive and which individuals are negative. For low disease prevalence settings, this innovative testing process leads to fewer overall tests, which subsequently lowers costs, when compared to testing specimens individually. Previous research in group testing has focused largely on testing for infections, such as HIV and chlamydia, one at a time. However, motivated by the development of new technology, disease testing practices are moving towards the use of multiplex assays that detect multiple infections at once. This research proposal presents the ﬁrst comprehensive extensions of group testing to a multiplex assay setting. The ﬁrst goal is to develop new group testing strategies that allow for multiplex assays to be used in sexually transmitted disease testing and blood donation screening applications. This will allow laboratories to obtain the maximum possible cost savings through proper applications of group testing. The second goal is to develop new group testing strategies to increase the classiﬁcation accuracy—both with single and multiple infections—in these same applications. This will be done by performing directed conﬁrmatory testing after individuals are initially classiﬁed as positive or negative. An overarching theme of this research is to acknowledge individual risk factors by incorporating them into the group testing process. In terms of biostatistical innovation, this research involves developing new classiﬁcation and Bayesian modeling procedures for correlated latent-variable data.

Public health relevance
Project Narrative Our research will provide new cost-effective approaches to test human populations for single and multiple in- fections. The public health community will beneﬁt in the form of reduced costs, quicker diagnoses, and fewer misdiagnosed individuals. Our research also provides public-health ofﬁcials the means to estimate disease risk probabilities more efﬁciently.